Traumatic Brain Injury and Sleep Disorders in Military Personnel

During this year, we have examined exosomes and the role of tau in TBIs from the above study. This year we have begun studies within the Center for Neuroscience and Regenerative Medicine to determine the role of biomarkers in the risk for fatigue and sleep disturbances. Many of these publications include fellows as a way to train individuals, as well as to provide opportunities for publications and completion of dissertations, for Katie Edwards and Heather Rusch. These studies combine biomarkers to provide insights into the mechanisms that relate to symptoms and disturbances following a TBI.